Core A: Administrative Core

The Administrative Core will provide for the administration of the Lymphoma SPORE, including administrative
and budget support for all SPORE investigators. The Administrative Core directly supports management of
SPORE projects, cores, and funds. Core A leverages existing institutional resources and infrastructure such as
research regulatory committees, clinical trial data collection and management, clinical trial budgeting, IND
development, technology licensing, and grants management. The Core will coordinate 1) monthly SPORE
meetings and seminars, 2) quarterly research meetings, lectures, and symposia, 3) the annual SPORE retreat,
4) meetings of the Executive Committee and the Internal and External Advisory Boards, and 5) participation in
NCI-sponsored SPORE meetings. This Core is involved with preparing and submitting annual progress reports
and making decisions regarding the selection and support of the best and most promising projects. Integration
and communication between the SPORE, the Department of Hematology and Hematopoietic Stem Cell
Transplantation, and the Cancer Center Support (Core) Grant will be promoted. Importantly, the Administrative
Core will be responsible for the oversight of the Developmental Research and Career Development Programs
in the Lymphoma SPORE. Finally, the Core will also promote patient interests and equitable access to
treatment on SPORE studies by working with a patient advocate to ensure that SPORE clinical studies are
patient-centered, and by facilitating recruitment of minorities and underserved populations to SPORE clinical
studies. Through performance of these objectives, the Administrative Core will ensure smooth functioning of
the SPORE to maximize our efficiency, conserve resources, and expedite scientific progress and achievement.

Public health relevance
The Administrative Core is responsible for the administrative and budget support for all SPORE investigators. This Core coordinates meetings and facilitates the selection and support of the most promising projects. Therefore, it is ensured that resources are best spent towards developing new breakthroughs that may benefit patients in need of novel treatments.